Ultrasound-programmable gene editing in kidneys

PROJECT SUMMARY
Greater than 60 genetic diseases are linked to impared kidney function, and single-gene kidney disorders
account for ~15% of end-stage renal disease. While CRISPR machinery holds significant therapeutic potential
to correct pathogenic renal mutations, there is currently a lack of clinically-relevant technologies available to
efficiently deliver CRISPR constructs to kidneys and precisely control gene editing in complex three-dimensional
renal tissue. This catalytic tool development project will establish renal-permissive and ultrasound (US) sensitive
fluorine nanomaterials capable of imaging-guided delivery of gene-editing ribonucleoproteins (RNPs) into renal
tubules. This technology will establish a powerful tool for the entire field. Fundamental to this strategy is our
discovery of a family of fluorochemical adjuvants, or ‘FTags’, that reversibly interface with proteins to enable their
loading into, and US programmable delivery from, acousto-responsive fluorous nanoemulsions, without
compromising the protein’s structure or bioactivity. Published studies from our group show that FTagged proteins
can be externally guided and activated in tissues using clinical diagnostic US to provide on-demand and
spatiotemporally controlled delivery of functional proteins in three-dimensional tissues in vitro and in vivo.
Leveraging this advance, and inspired by recent findings that deformable nanoparticles can passively
accumulate in kidney tubules, we will engineer these fluorous nanovectors to deliver base editing RNPs into
kidney tubules to affect gene repair of single-nucleotide polymorphisms; focusing on autosomal dominant
polycystic kidney disease (ADPKD) as an exemplary application. To achieve this, in aim 1 we perform rigorous
biochemical analysis of protein-FTag interactions en route to its methodologic optimization for Cas9:sgRNA RNP
base editors. Aim 2 will pair whole tissue fluorescence and B-mode/Doppler US imaging in ex vivo porcine
kidneys to mechanistically study renal localization of the carrier, and optimize conditions for synchronous
guidance and acoustic activation. Biophysical insights gained from these studies will be used to refine
nanoemulsion formulation to achieve compartment-specific renal localization, and to optimize acoustic activation
in kidneys using clinically relevant US pressures. In aim 3, pilot in vivo studies will quantitatively assess the
efficiency of US-programmed gene editing in kidney tissue using an RFP-reporter murine model. Parallel delivery
assays using Cas9 base editors will test specificity and efficacy of single-nucleotide polymorphism repair in PKD1
genes, and resultant modulation of cystogenesis in phenotypic models of ADPKD. Results will be benchmarked
against current liposomal RNP delivery systems to evaluate performance. Success of these high-risk/high-
reward studies will provide the foundation for a clinically-relevant, imaging-guided and quantitative gene-editing
tool for human kidney disease that leverages portable and non-invasive diagnostic US. We also expect to gain
mechanistic insights that may allow for future development of therapies against other genetic kidney disorders,
as well as novel diagnostic modalities and molecular biosensing technologies to probe renal function.

Public health relevance
PROJECT NARRATIVE Technologic advances that enable the precise delivery of gene editing tools into kidneys has the potential to treat a range of hereditable renal disorders. This project will develop a catalytic nanotechnology that leverages clinical ultrasound to provide on-demand and programmable delivery of CRISPR-Cas9 gene editing tools in kidney tissue to correct disease causing mutations.